ECM and shear stress

Project Summary Poor arteriogenesis, in which blood vessels parallel to an arterial blockage fail to remodel to restore blood flow to the affected tissue, is a major factor in illness and death in peripheral and coronary artery disease. This project is based on the hypothesis that arteriogenesis is initiated by elevated shear stress in small blood vessels that triggers a sequence of endothelial activation, inflammation, matrix remodeling, vessel expansion and resolution, which returns shear levels toward normal and restores normal vessel function. Artery remodeling is thus governed by a fluid shear stress set point such that when shear stress goes above or below the optimal range, ECs trigger a response to change vessel diameter and return shear toward the original value. The overall goal of this grant is to elucidate these mechanisms in more detail and identify restriction points that inhibit arteriogenesis in disease. Our preliminary and published data implicate extracellular matrix remodeling and smad activation as key components of these processes. Based on these results, we will: 1) Elucidate the role of matrix remodeling in arteriogenesis, specifically examining whether blocking a link between fibronectin and inflammatory pathways improve arteriogenesis in disease models. 2) Elucidate the signaling networks that govern the fluid shear stress set point. 3) Develop antibody- based tools that specifically alter the effects of flow on activation of Smad 2/3 vs Smad 1/5/8, and test their effects on arteriogenesis.

Public health relevance
Narrative Coronary artery disease and peripheral artery disease are major causes of illness and death in developed nations. Poor arteriogenesis is a critical determinant of these diseases and in patients’ recovery after myocardial infarction. This application proposes to elucidate the signaling network that governs flow-dependent vessel remodeling and test two new directions for improving arteriogenesis. These studies include testing whether blocking a link between inflammatory pathways and matrix remodeling improves arteriogenesis in disease models, and testing whether recombinant antibodies that modulate flow-induced Smad signaling can stimulate or inhibit arteriogenesis. These studies therefore have the potential to identify new targets and new reagents for therapy, as well as to achieve a deeper understanding of the fundamental biology that will form the basis for future studies.